NON-INVASIVE NEONATAL BLOOD PRESSURE MONITOR

DESCRIPTION (Adapted from applicant's abstract): The investigators propose to develop and test a neonatal blood pressure monitor which uses an inflatable bladder held adhesively to the temporal artery of the forehead. They have tested the concept in adult volunteers. The system provides an accurate blood pressure once per minute. The adult sensor will be modified for neonates, and the pad will be held on the palpable temporal artery just above the ear using hydrogel. The pad will inflate and deflate once per minute and report systolic, diastolic, and mean blood pressure. It will be tested in 20 neonates in the intensive care unit using an umbilical artery catheter as a reference.